Synergy of NF-kB and Notch signaling in B cell lymphomatous transformation and B cell plasticity

NF-kB and Notch signaling are activated in almost all common B cell lymphomas due to either activating
somatic mutations or upregulation of pathway regulators. However, how these two pathways synergistically
regulate B cell development and lymphomatous transformation are unclear. B cell plasticity has been
recognized clinically decades ago. Patient with B cell lymphoma occasionally develop clonally-related myeloid
tumors, suggesting that at least some myeloid tumors develop from malignant or premalignant B cells.
Clinically, these patients typically present with advanced disease with a poor prognosis due to diagnostic
difficulties and lack of standard treatment. The question is, how do B cells convert to myeloid lineage?
Experimentally, forced expression of myeloid transcription factor, CEBPa, in mature B cells induces B-myeloid
conversion. However, whether CEBPa initiates B-myeloid conversion in pathological conditions and whether
other signaling pathways are also involved are largely unknown. Our preliminary data show that concurrent
activation of both pathways in CD19+ B cells efficiently induces B cell lymphomatous transformation in sharp
contrast to activation of either pathway alone. Intriguingly and unexpectedly, transplanted doubly-activated
marginal zone precursor B cells, but not marginal zone B cells, converted to myeloid cells through
dedifferentiation, and some transformed to myeloid leukemia with clonal immunoglobulin VDJ recombination.
Our central hypothesis is that concurrent activation of NF-kB and Notch signaling accelerates B cell
transformation and triggers B-myeloid conversion mainly through downregulation of Bach2 and upregulation of
Ezh2. We will test this hypothesis with the following two independent specific aims: 1) To determine the
mechanism whereby concurrent activation of NF-kB/Notch signaling induces B cell transformation, and 2) To
determine the mechanism whereby concurrent activation of NF-kB/Notch signaling induces B-myeloid
conversion and transformation. The expected results are highly relevant to understanding the synergistic role
of NF-kB/Notch signaling in B cell plasticity and malignant transformation. Importantly, our results suggest that
adding Notch, NF-kB and/or Ezh2 inhibitors to the current lymphoma therapeutic regimens could not only
improve lymphoma treatment, but also prevent myeloid neoplasm conversion.

Public health relevance
NF-kB and Notch signaling are activated in almost all common B cell lymphomas. Patients with B cell lymphoma occasionally develop clonally-related myeloid tumors. Clinically, these patients typically present with advanced disease and have a poor prognosis due to difficulties in diagnosing them definitely and lack of standard therapeutic regimens. The proposed research aims to uncover the potential mechanisms whereby activation of NF-kB/Notch signaling in committed B cells induces lymphomatous transformation and B-myeloid conversion. As Hodgkin’s lymphoma and non-Hodgkin’s lymphoma are presumptive diseases associated with exposure to Agent Orange or other herbicides during military service, the results will facilitate our understanding and treatment of both lymphomas and those uncommon, but fatal myeloid neoplasms converted from B cells and thus improve the health of veterans.